Alignment of cortical development trajectories with emergent dimensional psychopathology and related risk factors among adolescents in the ABCD Study

PROJECT SUMMARY
Efforts to discover biological signatures for mental illness focus increasingly on adolescence, a period of
rapid brain development that immediately precedes the peak age of onset for many disorders. Maturation of
the cerebral cortex during this time has long been thought to mediate emergence of early symptoms. The
ongoing Adolescent Brain Cognitive Development (ABCD) Study provides an unprecedented opportunity to
align emergence of psychopathology with specific changes in cortical maturation within a diverse population of
nearly 12,000 youth. Enrolled at age 9-10, participants are being studied with 6 standardized MRI
assessments over a 10 year period, along with developmental history, genotype, and annual measures of
dimensional symptoms and of their home, school, and social environment. This application seeks to renew an
R01 grant that is focused on eliciting cortical developmental signatures of emergent psychopathology in ABCD
and triangulating these signatures with causal genomic and environmental risk factors. The award period
coincides with the second half of the ABCD Study (ages 14-20), and we will use publicly available data from
annual releases to test our hypotheses. Supported by findings from the first award period, our central scientific
premise is that (1) variance in late cortical thinning, as it proceeds along anterior and lateral brain territory, will
predict emergent psychopathology in late adolescence; and (2) progressive associations between thinning and
emergent symptoms will reflect a gradient of temporally distal (prenatal) to proximal (postnatal) risk factors.
Aim 1 will ultimately use all 6 biennial measures of cortical thickness and annual measures of dimensional
psychopathology from ages 9 to 20, enabling precise temporal and spatial alignment of cortical maturation and
symptom emergence. Aim 2 will consider this alignment within the frame of available postmortem
transcriptomic data, to assess the contributions of polygenic risk scores and temporospatial gene co-
expression programs from pre- and postnatal periods. Aim 3 will focus on pre- and postnatal environmental
risk factors, and will determine whether prenatal adversity and disruptions related to the Covid-19 pandemic
shape relationships between cortical thinning and emergent psychopathology. These analyses will be
supported by new methods that we developed during the last award period, including a rigorous quality control
pipeline for reducing measurement errors in structural MRI studies of children, and a novel method of parsing
polygenic risk based on pre- versus postnatal gene expression. By the conclusion of the proposed studies we
will establish specific cortical signatures that bridge causal factors with emergent psychopathology in
adolescence, and that can be leveraged for early recognition and intervention studies.

Public health relevance
PROJECT NARRATIVE Adolescence is a critical period for emergence of a range of psychiatric syndromes, as well as for maturation of the cerebral cortex. Investigators have long presumed these events to be linked, potentially in ways that can predict specific clinical outcomes, but until now we have lacked data from sufficiently large, prospective studies to establish definitive or tractable patterns. Leveraging data from the ongoing Adolescent Brain Cognitive Development Study, we will map emergent psychopathology across a range of symptoms to specific patterns of cortical development from age 9 to 20, and anchor these relationships to underlying genomic and environmental risk factors.